Optimizing Individualized and Adaptive mHealth Interventions via Control Systems Engineering Methods

Background: While reinforcement schedules are, in general, understood to be valuable for behavioral change,17-
19 maintenance,20-22 and adherence,23,24 there is still much more research needed to better understand the
mechanisms of action (MoA) for these processes, such that more robust digital health interventions can
incorporate them, systemically and at scale. The Parent R01 approach for continuously adapting support
includes two states: the initiation state in which it relies on a continuous reinforcement schedule and a
maintenance state in which it shifts to the use of a variable reinforcement schedule. Primary purpose: To
systematically study the dynamic MoA of reinforcement schedules, on behavior change, via computational
modeling and rigorous secondary analyses. Hypotheses: We hypothesize that 1) idiographic “black-box”
dynamical models can identify key measured social cognitive theory (SCT) constructs like self-efficacy, that are
important to understanding behavioral maintenance; 2) the use of grey-box/semi-physical models, incorporating
reinforcement schedules into models, will explain a larger portion of variance, and 3) Model-on-Demand with
Simultaneous Perturbation Stochastic Approximation (MoD-SPSA) approaches will identify optimal model
structure, and adjustable parameters in the estimation method that better fit non-linear assumptions. Methods:
We will build on our previously validated SCT dynamical model, which is foundational to the Parent R01, but with
added incorporation of key insights about reinforcement schedules incorporated into the model structures. Then,
using the data generated from first 100 participants of the Parent R01 clinical trial (see research strategy for our
approach to ensure trial integrity), we will conduct “black-box” auto-regressive dynamical models, which does
not incorporate prior domain knowledge, save SCT variable selection. Next, we will conduct “grey-box” modeling,
which is much like a dynamical structural equation model in that it incorporates prior domain knowledge into the
mathematical model. Increased percent variance explained of steps/day of the grey-box modeling is indicative
of the added value of prior domain knowledge about the MoA of reinforcement learning, thus a robust test of this
dynamic MoA. Finally, we will use MoD-SPSA25 as an aid for identifying optimal features, model structure, and
adjustable parameters in the estimation method, to examine potential nonlinear interactions and relationships.
Implications: This research has a number of synergistic benefits including: 1) it will generate rigorous scientific
evidence for better understanding the MoA, reinforcement schedules, for behavioral maintenance; 2) it will
produce key novel ways to operationalize, dynamically, different reinforcement schedules for fostering behavioral
maintenance via digital health interventions; and 3) for the Parent R01, this research will allow the approaches
and techniques to be refined with a specific emphasis on improving behavior maintenance. Thus, this
supplement remains within the original scope of the parent award and will maximize the impact of the knowledge
gained from it, especially for advancing the behavior maintenance with the behavioral theory testing.

Public health relevance
Project Narrative: Reinforcement schedules are understood to be valuable for behavioral change, maintenance, and adherence, however, more research is needed to understand reinforcement schedules to allow them to be incorporated in digital health interventions at scale. The purpose of this supplement is to conduct rigorous analyses to better understand reinforcement schedules, to improve fundamental knowledge about this important mechanism of action. Our novel approach will generate rigorous scientific evidence that could advance fundamental knowledge that could result directly in improving health via digital health interventions.